Load dependent properties of a single molecular motor determines ensemble behavior

Project Summary
Many complex cellular processes from muscle contraction to vesicular transport are driven, not by a single
myosin motor, but by the coordinated action of teams of motors. A key unanswered question is how do single
motors couple and coordinate their activity in ensembles to give rise to these complex cellular processes? This
knowledge gap is preventing a detailed molecular understanding of a host of intracellular processes, as well as
the development of therapies for diseases that result from the dysfunction of these processes. A widely held
view is that teams of myosin molecules coordinate their activity through their ability to sense the magnitude
and direction of an applied load. However, this idea has not been fully, nor directly, tested in part because
myosin’s biochemical and mechanical transitions occur faster than most existing technologies can resolve.
Thus, it is still not clear which step or steps in the cross-bridge cycle are load sensitive, and what the specific
nature of these load-sensitivities are. To gain this knowledge I have developed novel laser trap assay methods
and analyses with the necessary spatial and time resolution to directly characterize the load-sensitive steps in
myosin’s mechanochemical cycle. These data will be used to develop molecular models of single molecule
behavior under a variety of conditions. I then use the mini-ensemble laser trap assay to directly characterize
how ensembles of motors work together to generate force and motion, providing the first direct test of our
models and the information needed to refine and improve the models. To date I have focused primarily on
muscle myosin II, but recently I have begun taking similar approach to characterize the behavior of the
processive motor, myosin Va. And I now plan to expand this approach to investigate the two other classes of
myosin V motors (Vb and Vc) and myosin III to better understand the complex processes that they drive within
the cell. If this work is successful the information will transform our understanding of molecular motors by
providing the first complete molecular explanation of how these prototypical molecular motors coordinate their
activity. This will then provide crucial insight into how these motors drive many complex cellular processes, and
by doing so will reveal novel molecular targets for more effective therapies for a host of myosin associated
diseases.

Public health relevance
Narrative Myosin motors work in a cooperative manner to drive many processes within the cell; from muscle contraction to intracellular transport. The dysfunction of these processes is associated with a wide range of pathologies from heart failure to neurological disorders, therefore if the cause of the dysfunction could be identified, and reversed, it would present powerful targets for a myriad of pathologies. I will characterize the load-dependence of the rapid mechanical and biochemical events of myosin’s chemo-mechanical cycle using novel single molecule and a mini-ensemble laser trap assays and construct models to understand how teams of molecular motor drive complex cellular processes.